Administrative Core

PROJECT SUMMARY (See Instructions): The UCSF-GIVI CFAR Administrative Core develops and coordinates all leadership functions of the Center and advances its mission of promoting multidisciplinary translational HIV research. The Core creates a true

Public health relevance
The UCSF-GIVI CFAR Administrative Core coordinates all operations of the Center focusing on advancing the Center's mission of promoting multidisciplinary translational HIV research. The Core brings members together, leads in strategic planning and maintains an active dialog with the UCSF and Bay Area communities. The Core provides financial management that increases the overall effectiveness in helping control the domestic and global HIV epidemics.